Selection in utero and consequences for sex differences in adult mortality: a cohort approach

Project Summary (30 lines)
Male cohort lifespan falls below female lifespan in all societies with reliable data. Although this male longevity
deficit is well-described, less attention focuses on heightened male frailty in utero. Empirical work as well as
strong theory indicates that the sex ratio at birth (i.e., M/F) gauges the strength of mortality selection in utero
especially for males that ultimately survive to birth. We will test an innovative hypothesis which connects this
frailty in utero to morbidity and mortality in older adulthood―specifically, whether males more than females
born to the most selected birth cohorts show reduced morbidity and mortality rates at advanced ages. The
“culled cohort” argument asserts that males born to low sex ratio cohorts live longer, on average, than
expected because the frailest members of their group were culled in utero. Ecological analyses in industrial
Europe find that males (but not females) born from the most culled cohorts (i.e., low sex ratio) exhibit lower
than expected mortality rates at older ages. We intend to move beyond these ecological associations and
test, using longitudinal, individual-level life history data from a high-fertility population whether the sex ratio
at birth predicts sex differences in survival and morbidity (e.g., cardiovascular disease) beyond age 50. We
will examine over 1.7 million males and females from the Utah Population Database (UPDB), born from 1850-
1940 and followed until the present (i.e., most cohorts will no longer have living members). The UPDB is one
of the largest and highest quality individual-level life history databases in the world which may identify frail
subgroups. Our aims will examine whether the hazard rate (≥50 years) of all-cause mortality, “biological”
causes of mortality, and cause-specific morbidity varies for males more than females as a function of the
cohort’s sex ratio. For all aims, we will (i.) examine males and females separately; and (ii.) test whether family
and individual life-history characteristics (e.g., parental investments, SES), which may gauge phenotypic
plasticity, attenuate or magnify any cohort effects of the sex ratio. All analyses will control for secular patterns
in mortality, cohort attrition before age 50, shared family frailty, and other relevant confounders. We will also
examine ambient stressors (e.g., Great Depression) as well as highly localized (e.g., drought at the county
level) antecedents of selection in utero and later-life cohort mortality. Hypotheses will be tested with rarely
combined but well-developed methods. Overall, our work is significant because it advances NIA’s research
priority of “understanding sex and gender differences in health and disease at older ages.” Results will also
inform the developmental origins field in that researchers measuring older-age responses (e.g., chronic
disease) to ambient stressors during pregnancy may underestimate later-life adversity if they do not account
for heterogeneity of frailty in utero. Lastly, identifying frail subgroups within a cohort (e.g., males with CVD),
as well as uncovering life-course variables that gauge phenotypic resilience, would hold implications for
understanding the biological and social basis of male/female differences in survival.

Public health relevance
Project Narrative (Relevance to Public Health) The proposed work directly tests sex differences in morbidity and mortality rates at older ages in response to cohort selection in utero. Our project may ultimately assist in connecting life history theory to predictions regarding male more than female mortality rates at advanced ages. In addition, results may identify subgroups that, by virtue of their birth cohort and individual-level life course experience, appear most susceptible to greater risk of common chronic disease (e.g., cardiovascular disease).